Tools and technology for high-fidelity mesoscale diffusion MRI

PROJECT ABSTRACT
The NCBIB P41 Center for Mesoscale Mapping (CMM) is dedicated to driving the convergence of tools and
technologies for imaging and probing human brain structure and function at the mesoscopic scale. Technology
Research and Development (TRD) Project 3 focuses on developing high-fidelity mesoscale diffusion MRI tools
and technologies for investigating human brain microstructure and connectional anatomy at unprecedented
resolutions, taking advantage of advances in MRI hardware over the past two decades. The greater availability
of high-performance gradients and ultra-high field strengths for MRI is increasingly allowing for imaging of tissue
microstructure at the mesoscopic scale, yet such hardware advances also pose significant challenges to
obtaining high image quality throughout the whole brain. TRD3 seeks to overcome these limitations by
developing high-fidelity, high-spatial resolution acquisition technology and interpretive frameworks, unlocking the
full potential of high-performance MRI systems for acquiring biological insights at the mesoscopic scale. By
integrating advanced diffusion-relaxometry methods, we aim to generate parametric maps of cellular-scale
biophysical properties, providing insights into brain structure and organization across multiple scales. TRD3 will
tackle technical challenges related to imaging at ultra-high field strengths, including motion artifacts, eddy current
distortions, and field inhomogeneities. Our work will focus on three key objectives: (1) Developing robust sub-
millimeter acquisition techniques for artifact-free diffusion MRI, (2) Innovating on parallel transmit (pTx) strategies
to achieve uniform spin-echo diffusion MRI at 7T, and (3) Creating tools to link mesoscale diffusion MRI data
with the underlying tissue microstructure. These technologies will offer powerful new tools for fundamental
neuroscience research, with applications to understanding brain organization and the biological basis of
neurological and psychiatric disorders.